Pilot Project Program

PROJECT SUMMARY – Pilot Project Program
The overall goal of the Pilot Project Program (PPP) is to expand the UC Davis research base in environmental
health sciences (EHS) and to attract new or established investigators to turn their attention to health issues
related to environmental exposures. The PPP will promote EHS research through provision of research
funding, facilitating linkage of applicants to resource cores and Design Clinics, provision of intellectual support,
as well as integration within the Center, and with other programs at UC Davis. PPP application calls include the
needs of community partners impacted by environmental exposure and injustice or that have a policy interest.
Research funds are expected to jumpstart new research endeavors focused on environmental health, through
feasibility investigation, collection of preliminary data, establishment of proof of principle or small studies that
are consistent with the broad mission and scientific themes of the Environmental Health Sciences Core Center
(EHSCC) and NIEHS. We will focus on projects with relevant translational potential and those that hold
promise for generating new resources or approaches to address environmental health problems. This Program
will emphasize support for junior investigators, as well as those investigators new to environmental health or
exploring substantially new research directions and whose research brings an innovative viewpoint to the study
of environmental health with relevance to human conditions. Support will also be provided to established EHS
researchers exploring new directions or developing new devices or tools for EHS research. Available funds for
the PPP were, and continue to be, greatly enhanced through partnerships with other programs and academic
departments on the UC Davis campus. The PPP process involves: 1) issuing a request for proposals, 2)
reviewing preproposals,3) referring applicants to Facility Core Design Clinics for guidance, 4) finding reviewers,
and 5) reviewing proposals for both scientific and programmatic merit, with final funding decisions made by the
Center Leadership Group and Community Advisory Committee Representatives. The specific objectives of
the PPP are to: (a) provide support for junior investigators and/or established researchers new to EHS to
develop a research program in EHS; (b) facilitate exploration of innovative new directions to advance EHS
research; (c) develop resources, approaches, or technology that benefit EHS research for center members; (d)
promote interdisciplinary research; and (e) promote community engagement and translational research. The
significance of this program is underscored by the need to support and promote the careers of junior and
under-represented faculty as well as to expand innovative research that has translational benefit for our
stakeholders and communities.